Treatment of OSA on sleep-dependent memory and blood biomarkers in blacks

PROJECT SUMMARY.
Growing evidence suggests that obstructive sleep apnea (OSA) patients have cognitive impairments as well as
increases in Alzheimer's disease (AD) biomarkers such as amyloid beta and tau. Positive airway pressure (PAP)
therapy is an effective treatment for OSA but is often limited by suboptimal adherence. Anecdotal evidence show
both short and long-term adequate OSA treatment improving attention, psychomotor speed, memory and
executive function deficits associated with OSA. However, there is scarcity of data regarding the impact of OSA
treatment among blacks on neurocognitive outcomes, despite having a disproportionate burden of OSA and AD,
as well as a traditionally low treatment adherence. In this innovative hypothesis-driven study, we will address
inadequate adherence to OSA treatment in blacks with “personalized multi-modal OSA treatment”, tailored to
reduce health risks in minoritized communities by offering any combination of PAP, oral appliance therapy
(OAT) and positional therapy, as well as address individual and system-level barriers through no-cost
enrollment, personalized educational/instructional use, and real-time adherence monitoring that results in an
effective reduction in AHI. Using a pre-and-post treatment design, we will examine the personalized multi-modal
OSA treatment effect on within-subject changes on i) blood-based biomarkers of neurodegeneration (Aim 1), ii)
sleep-dependent spatial navigational memory and functional magnetic resonance imaging (fMRI) (Aim 2), and
iii) examine whether adequate sustained reductions in AHI at 12 months (effective AHI<15) are associated with
sustained improvement in global cognition, standard declarative memory, attention and processing speed tests
(Aim 3). Our central hypothesis is that the degree of effective AHI reduction by our personalized multi-modal
OSA treatment will predict: 1. the longitudinal change in overnight plasma NfL; 2. the longitudinal change in
brain circuit activity and spatial navigational memory improvement and 3. the degree of sustained improvements
in sleep and cognitive performance at 12-months.We will leverage the success of our Sleep Disparity Workgroup
in recruiting from minoritized communities, and the collaboration with affiliated sleep clinics and test our central
hypothesis in a sample of 60 newly diagnosed moderate-to-severe OSA black subjects ages 45-75. Subjects will
undergo full clinical evaluation, neuropsychological tests and clinical labs. Prior to and after 3-months of
personalized multi-modal OSA treatment, all subjects will undergo a night of in-lab polysomnography with a
pre-sleep and post-sleep blood draw and spatial navigational memory test in the MR scanner. A 12-month follow-
up will also assess the effect of sustained improvements in sleep on changes in cognitive performance.
Importantly, we will acquire and explore identifying socio-structural determinants of health (SDOH) factors that
are associated with sustained treatment adherence to inform both clinical and public health practices targeting
inadequate adherence and impact of OSA treatment on cognition in blacks.

Public health relevance
Project Narrative/Relevance to Public Health. Obstructive Sleep Apnea (OSA) increases Alzheimer’s disease (AD) risk, however there is scarcity of data regarding the impact of OSA treatment among blacks on neurocognitive outcomes. In study, we aim to address inadequate adherence to OSA treatment in blacks with “personalized multi-modal OSA treatment”, tailored to reduce health risks in minoritized communities through no-cost enrollment, personalized educational/instructional use, and real-time adherence monitoring that results in an effective reduction in AHI.